Nociplastic mechanisms in temporomandibular disorders: Separating nociception from pain

Project Summary: Quantitative sensory testing (QST) is widely used to make inferences about pain processing
mechanisms, including how processing is disrupted in chronic pain. However, it is usually not possible to
separate nociceptive from pain sensitivity in these studies. For QST, this means that true, unbiased nociceptive
sensitivity cannot be measured using psychophysical techniques that have provided insight into other sensory
modalities. To overcome these challenges, we developed a method to selectively stimulate nociceptors by
locating fairly large (>2.56 cm2) naturally occurring areas of skin that are completely devoid of innocuous warm
fibers. By applying noxious heat to these warmth-insensitive regions, we are able to obtain unbiased measures
of nociceptive sensitivity and compare those with measures of pain sensitivity using the same stimuli (noxious
heat). Nociplastic pain, which is a different mechanistic category from nociceptive and neuropathic, is present in
many chronic pain conditions, including temporomandibular disorders (TMD). However, some patients likely
have more nociplastic mechanisms than others. To extend our knowledge of the mechanisms contributing to
nociplastic pain, this project will enroll both pain-free individuals and those with TMD and employ 1) standardized
QST procedures for assessment of nociplastic pain, multimodal sensory hypersensitivity, and comparison with
other chronic pain conditions like neuropathic pain and fibromyalgia, 2) a novel nociceptive-specific heating
(NoSH) protocol to measure the sensitivity of nociceptors in relation to the perception of pain, and 3) a variety of
endogenous pain-modulatory processes that might contribute to nociceptive and/or pain hypersensitivity in
patients with nociplastic pain. We hypothesize that a subset of TMD patients will display highly probable
nociplastic pain according to the clinical grading criteria. Based on preliminary data, we hypothesize that pain
hypersensitivity is related to suprathreshold mechanisms that modulate nociceptive signals differently in
nociplastic pain. Success in this project could also lead to development of a new clinical biomarker for assessing
nociception and pain in isolation.

Public health relevance
Project Narrative We have developed a method to psychophysically measure nociceptive sensitivity as a separate entity from pain sensitivity. Nociceptive sensitivity will be measured in patients with temporomandibular disorder, some of whom have nociplastic pain features. We will compare their nociceptive and pain sensitivity with data from pain-free controls, which may constitute a novel biomarker for use in other mechanistic studies and clinical trials and give insight into the mechanisms underlying pain hypersensitivity in patients with nociplastic pain.